Mechanisms underlying centriole morphogenesis

PROJECT SUMMARY/ ABSTRACT
The heart of the centrosome, the microtubule organizing center, is composed of two centrioles. The two
centrioles are not equal. The older of the two, called the mother centriole, differs structurally from the younger,
daughter centriole. Mother centriole-specific structures confer the unique capability to nucleate the primary
cilium, an organelle that serves as the cell’s antenna. Consequently, defects in centriolar proteins can cause
human ciliopathies, diseases caused by disrupted ciliary function. Despite being universal features of vertebrate
cells, how the mother and daughter centrioles differ and how centrioles are built remain mysterious. I uncovered
a complex of proteins comprised of CEP90, MNR and OFD1 (which I have named DISCO for DIStal Centriole
cOmplex) required for proper centriole morphogenesis. Mutations in DISCO components cause Joubert and
Orofaciodigital syndromes, disorders of brain, face and limb development. By studying this novel centriolar
complex, I seek to understand how centrioles are built, and how they are remodeled to support cilium
assembly. Using an innovative combination of expansion and structured illumination microscopy (Ex-SIM), I will
define how components of this complex structure the distal centriole and how human disease-associated
mutations disrupt this sub-compartment (Aim 1). MNR and OFD1 control centriole length by an unknown
mechanism. Using super-resolved imaging and biochemical assays, I will uncover molecular mechanisms by
which centriole length is established by MNR and OFD1 (Aim 2). CEP90 and MNR are also components of
centriolar satellites, poorly understood membrane-less granules surrounding the centrosome. I have found that
centriolar satellites display hallmarks of phase separation. Using live-imaging and in vitro biochemical
reconstitution, I will test the hypothesis that CEP90, MNR and OFD1 are trafficked to the centriole by phase-
separated centriolar satellites to support ciliogenesis (Aim 3). With the help of an outstanding advisory
committee, I will train in advanced imaging and biophysical techniques that will allow me to address fundamental
questions on how centrioles and cilia are built. Spanning both the mentored and independent phases, these
studies will illuminate how human disease-associated proteins build and modify centrioles to allow cilium
biogenesis, and create a strong foundation for an independent research career studying the role of centrioles
and cilia in human development and disease.

Public health relevance
PROJECT NARRATIVE Centrioles are highly conserved cellular organelles that serve as platforms for assembly of centrosomes and cilia. Cilia are sensory and signaling organelles that play crucial roles in development. Several human diseases impacting multiple tissues are caused by centriole or cilia defects. This proposal focuses on understanding how centrioles are built and modified to support cilium assembly, with the goal of revealing molecular etiologies of centriole- and cilia- associated diseases, such as Joubert and Orofaciodigital syndromes.